Operationalizing DNMT1-Targeting to Treat Chemorefractory Pancreatic Cancer

Pancreatic ductal adenocarcinoma (PDAC) is a recalcitrant, deadly problem. Most PDAC patients receive
aggressive multi-agent chemotherapy but median overall survivals remain at <1 year. A well-established basis
for limited chemotherapy response is mutation and deletion of the master regulator of apoptosis p53 in most
PDAC. Thus, alternative treatment modalities that do not rely on p53 are needed. The key epigenetic regulator
DNA methyltransferase 1 (DNMT1) is a scientifically validated molecular target to cytoreduce chemo-refractory
malignancies including PDAC, since it effects cancer cell cycling exits by p53-independent epithelialization.
DNMT1 can be inhibited/ depleted by the pyrimidine nucleoside analog pro-drugs decitabine (Dec) or 5-
azacytidine (5Aza), approved to treat myeloid malignancies. However, results from several completed clinical
trials using Dec, 5Aza, or analogs to treat PDAC and other solid tumors have disappointed. A reason for this
was suggested by correlative studies that revealed failure of Dec to elicit DNMT1-inhibiting pharmacodynamic
effect in >75% of solid cancer tissues. We explored reasons for this further, in both pre-clinical and clinical studies
we found inherent and adaptive configurations of pyrimidine metabolism in PDAC cells that forestall Dec or 5Aza
processing into DNMT1-depleting nucleotide. Fortunately, there are practical modifications to therapy that can
counter these mechanisms of resistance to DNMT1-targeting by Dec/5Aza. Specifically, we hypothesize that
resistance to Dec, 5Aza emerges from adaptive responses of pyrimidine metabolism that can be anticipated and
exploited using alternative schedules, and by combination with non-toxic modifiers of pyrimidine metabolism.
Aim 1: Evaluate schedules of Dec and 5Aza administration designed to exploit peaks/troughs in
pyrimidine metabolism adaptation and increase S-phase dependent DNMT1-depletion. Our prelim data
indicates that scheduling Dec/5Aza administration to exploit reactive peaks and troughs in key pyrimidine
metabolism enzymes, and frequent, distributed administration to increase overlap between malignant cell S-phase entries and treatment exposures, adds substantial benefit in vivo – we will extend this data to guide
mechanistically-rational, readily implementable schedule improvements to clinical therapy. Aim 2: Enhance
non-cytotoxic DNMT1-targeting by combining Dec and 5Aza with non-cytotoxic modifiers of pyrimidine
metabolism. We have found that auto-upregulation of cytidine deaminase (CDA) that rapidly catabolizes
Dec/5Aza, and of de novo pyrimidine synthesis that competes with Dec/5Aza for incorporation into DNA,
contributes critically to resistance. We will therefore combine Dec/5Aza with clinical non-cytotoxic inhibitors of
catabolic and de novo pyrimidine metabolism pathways, to identify combinations that increase DNMT1-targeting,
response rates and durations. The treatment concepts we evaluate here are practical for clinical translation, e.g.,
we have developed into the clinic oral forms of CDA-inhibitor+Dec/5Aza that are readily combined with clinical
inhibitors of de novo pyrimidine synthesis, to rapidly translate pre-clinical proof-of-principle into clinical therapy.

Public health relevance
PROJECT NARRATIVE Despite the substantial intensity and toxicity of standard treatments for pancreatic cancer, median overall survival is <1 year. Although several reasons for limited chemotherapy responsiveness have been proposed, a well- established basis is mutation and deletion of the master regulator of apoptosis (cell death/cell suicide) p53. Thus, we develop and refine a novel modality of treatment that does not require p53; importantly, the regimen for which we propose to generate pre-clinical in vivo proof-of-principle is practical for rapid translation into clinical therapy.